EXPRESSION OF IMMUNOGLOBULIN HEAVY CHAIN GENES

The long term goals of this application are to define the molecular requirements and regulation of immunoglobulin heavy chain constant region gene switch (S) recombination in B lymphoid cell development. Our strategy is largely based on the introduction of retroviral vectors harboring immunoglobulin gene recombination sequences into lymphoid and non-lymphoid cell lines. Recombinant DNA techniques will be employed to determine the molecular constraints and minimal requirements for S region recombination. Appropriate vectors will also be prepared to screen for putative CH isotope specific switch-recombinases. The presence of CH switch-recombinase activity will be assayed in cell lines representative of various stages of B cell development and the effects of lipopolysaccharide (LPS) and interleukins which cause B cell differentiation, such as IL-4 will also be determined. In a second specific aim, we will study B cell specific nuclear factors, which bind to S region sequences, to determine their potential role(s) in switch recombination. In a third objective, the nuclear run-on transcription technique will be employed to directly determine if transcriptional activation of CH genes predetermines CH switch-recombination in differentiating B cells. We will also investigate the regulation of sense and anti-sense transcripts of unrearranged CH loci and their potential significance for the switch recombination mechanism. Finally, we plan to clone Igh switch-recombinase gene(s) from a mammalian expression vector cDNA library by a convenient, selectable rescue strategy. Here, thymidine kinase negative fibroblast cell lines harboring stably integrated, though recombinationally inert, retroviral Igh gene recombination substrates will be transfected with a mammalian expression vector cDNA library prepared from the mRNA of an Igh recombination competent pre B cell line. The loss of a thymidine kinase marker gene inserted in between our retrovector's Igh recombination sequences will be selected for in bromodeoxyuridine (BudR) media. By this selection strategy, cDNA clones which could encode a switch recombinase responsible for TK gene deletion will be identified and characterized. These objectives will enable us to dissect the molecular basis and developmental control of a key process in immune response maturation.